Protein O-GlcNAcylation in Regulatory T Cell Function

PROJECT SUMMARY
Regulatory T (Treg) cells, characterized by the expression of FOXP3, are a distinct lineage of T lymphocytes
that control immunological self-tolerance and tissue homeostasis. These cells are associated with a multitude of
human diseases, such as autoimmune disease, inflammation, organ transplant rejection, and some infections
and cancers. The biomedical community has developed an intense interest in targeting Treg cells for
immunotherapy; however, significant barriers, for example Treg-cell functional heterogeneity and instability,
need to be surmounted in order to achieve clinical feasibility. The proposed study aims to understand a novel
molecular mechanism that control the stability and function of Treg cells. Our preliminary data have found that a
novel O-linked N-Acetylglucosamine (O-GlcNAc) protein modification, activated by T-cell receptor (TCR)
signaling, is indispensable for the suppressive function of Treg cells. Treg cell-specific knockout of O-GlcNAc
transferase (OGT), the enzyme catalyzing O-GlcNAcylation, does not affect Treg cell lineage specification but
results in the development of an aggressive autoimmune syndrome in mice. O-GlcNAcylation modifies and
stabilizes FOXP3 protein and transcriptomic analyses have revealed that IL-2/STAT5 signaling is suppressed in
OGT-deficient Treg cells. Therefore, we hypothesize that TCR-initiated protein O-GlcNAcylation modulates
FOXP3 and STAT5, thereby linking TCR and IL-2 signaling pathways, to regulate Treg cell homeostasis and
effector function. In Aim 1, we hypothesize that loss of O-GlcNAcylation destabilizes FOXP3 protein, eliminating
the suppressive function of Treg cells and converting Treg cells into effector T cells. We will determine whether
O-GlcNAcylation counteracts ubiquitination to stabilize FOXP3 protein, thus maintaining the Treg identity. By
generating FOXP3 mutant mice, in which O-GlcNAcylation is specifically abolished, we will test whether FOXP3
O-GlcNAcylation is required for the suppressive activity of Treg cells. In Aim 2, we propose to examine the effect
of STAT5 O-GlcNAcylation on Treg cell suppressive function. We will test the hypothesis that O-GlcNAcylation
controls IL-2-stimulated STAT5 activation in Treg cells and FOXP3 and STAT5 act cooperatively to mediate the
effect of protein O-GlcNAcylation in Treg cell function. In Aim 3, we will identify the molecular link between TCR
and O-GlcNAcylation in Treg cells. We will test the hypothesis that TCR signaling promotes protein O-
GlcNAcylation and Treg cell suppressive activity in a Ca2+/CaMKII-dependent manner. Lastly, through unbiased
O-GlcNAc proteomics, we will characterize TCR-regulated protein O-GlcNAcylation profile and identify potential
complementary mechanisms for O-GlcNAc-mediated Treg cell function. The proposed study will stimulate the
opening of a new avenue in therapeutics directed to activate and maintain Treg cells for immunotherapy.

Public health relevance
PROJECT NARRATIVE Regulatory T (Treg) cells is an attractive immunotherapeutic target to treat autoimmune diseases; however, clinical implementation of Treg cell immunotherapy has been challenging, represented by the functional heterogeneity and instability of these cells. The proposed study will test the novel hypothesis that upon T-cell receptor activation, protein O-GlcNAcylation modulates FOXP3 and STAT5 to control the effector function and stability of Treg cells. This study will help surmount the barriers we currently face in translating Treg cells immunotherapy to clinical practice.